A patient preference trial of sublingual versus extended-release buprenorphine telemedicine and pharmacy linkage for individuals re-entering the community from jail

Abstract
This proposed study is a patient preference trial (PPT) of XR-B vs. SL-B in 8 rural jails in Maryland. A total of
500 adults with moderate/severe OUD soon-to-be-released from jail will be recruited and will choose to receive
XR-B or SL-B treatment in jail via telemedicine followed by 6-months of post-release XR-B/SL-B treatment via
telemedicine at community pharmacies, a 7-month safety visit, and 12-month follow-up. All individuals
receiving XR-B will have their injection administered by a pharmacist, allowing the telemedicine treatment to be
fully remote and equivalent to that of SL-B which will also be filled at a local pharmacy. In addition, the
consolidated Framework for Implementation Research (CFIR) and Reach, Effectiveness, Adoption,
Implementation, and Maintenance (RE-AIM) framework will be utilized to understand implementation of
telemedicine of XR-B and SL-B in jails and continued at community pharmacies. Aim 1. Compare the
effectiveness of XR-B vs. SL-B in terms of: Primary Outcome. (a) retention in buprenorphine treatment (i. days
receiving buprenorphine and ii. time to treatment dropout). Secondary Outcomes. (b) illicit opioid use (i. urine
toxicology; ii. self-reported days of opioid use; and iii. time to opioid relapse); (c) other illicit substance use (i.
urine toxicology; ii. self-reported days of illicit substance use; (d) overdose events (non-fatal and fatal); (e)
health-related quality of life (i. physical health; ii. mental health); (f) HIV risk behaviors (i. sexual risk behavior;
ii. needle use or sharing); and (g) criminal activity (i. crime days; ii. re-arrest; iii. technical violations; iv. re-
incarceration). Aim 2. Document factors relevant to implementation and sustainability of the telemedicine
buprenorphine intervention in jails and pharmacy settings. Guided by CFIR and RE-AIM we will gauge 1) how
to optimize key intervention components (e.g., dose induction, telemedicine procedures, medication
preferences, continuity of care, inner and outer context factors, stigma, pharmacy procedures, improvement of
the cascade of care for OUD) and 2) the RE-AIM of key implementation factors. To achieve this aim, we will
conduct interviews with stakeholders (n = 10, e.g., pharmacists, telemedicine providers, jail staff per site; total
n = 80). The study will be innovative for two reasons: 1) it would be the first large scale PPT of XR-B/SL-B
using telemedicine among individuals leaving jail; and 2) it would be the first study continuing XR-B injections
with a re-entry population at pharmacies. The study will be highly significant because most individuals with
OUD do not receive treatment while in jail, thereby substantially raising their likelihood of relapse to drug use,
overdose death, and re-incarceration when they are released. A telemedicine program may improve the
continuity of care between incarceration and re-entry which is the period in which individuals with an OUD are
most vulnerable. Finally, understanding how to expand acceptance of MOUDs in jails using telemedicine and
pharmacy administration of XR-B, has far-reaching implications for expanding treatment access.

Public health relevance
Project Narrative The proposed study will be innovative for three reasons: 1) it would be the first large scale patient preference trial (PPT) of extended-release buprenorphine (XR-B) and sublingual buprenorphine (SL-B) using telemedicine among individuals leaving jail and re-entering the community; 2) it would be the first study continuing XR-B injections with a re-entry population at community pharmacies; and 3) the development of implementation toolkits for jails and pharmacies could help to expand access to buprenorphine for individuals detained in or returning to the community from jails. To our knowledge there have been no controlled studies in the US implementing XR-B on-site at community pharmacies. The study will be highly significant because most individuals with OUD do not receive treatment while in jail, thereby substantially raising their likelihood of relapse to drug use, overdose death, and re-incarceration when they are released. A telemedicine program may improve the continuity of care between incarceration and community re-entry which is the period in which individuals with an OUD are most vulnerable. Finally, understanding how to expand acceptance of MOUDs in jails using telemedicine and linking to community pharmacies has far-reaching implications for expanding treatment access in this population.